Blood brain barrier integrity and immune dynamics contributing to neuropsychiatric sequela in COVID long-haulers

PROJECT SUMMARY/ABSTRACT
A substantial (>35%) proportion of patients acutely infected with SARS-CoV-2 demonstrate neurological
symptoms ranging from serious headaches to encephalopathy, stroke, seizure, and acute neuropathies.
However, some patients experience lingering or emergent neuropsychiatric symptoms within weeks to months
following acute infection. The neuropsychiatric burden among COVID long-haulers is a major issue; and yet the
underlying pathophysiology of these conditions remains elusive. SARS-Cov-2 infection results in increased
levels of circulating proinflammatory cytokines/chemokines and elevation of intermediate monocyte
(CD14+CD16+) subsets in blood. Trafficking of these proinflammatory monocytes into the brain of individuals with
other chronic viral infections (eg. HIV) has emerged a putative contributor to neuroinflammation, blood brain
barrier (BBB) disruption and may explain the ongoing neurological sequalae in COVID long-haulers. We propose
to test our hypothesis that COVID long-haulers will have BBB disruption mechanistically linked to targeted,
circulating proinflammatory cytokines/chemokines and elevation of intermediate monocytes that traffic to the
brain. Monocyte infiltration in response to infection is a hallmark of CNS inflammation and occurs consistently in
chronic conditions. Thus, we further hypothesize that disruption in BBB integrity by intermediate monocyte
activation and diapedesis promotes persistent neuroinflammation and altered neuronal activity, contributing to
neuropsychiatric sequela COVID-19 long-haulers. To this end, we propose cross-sectional imaging to assess
BBB integrity, with neuropsychiatric assessments, and immunophenotyping in 100 COVID long-haulers and 100
individuals who have recovered from acute COVID (control group). First, we aim to assess BBB integrity in
COVID long-haulers (vs. control) and its contribution to neuropsychiatric conditions. We will assess BBB integrity
using a novel, non-contrast magnetic resonance imaging technique that uses water-extraction-with-phase-
contrast-arterial-spin-tagging (WEPCAST), to determine BBB permeability to small molecules. We have shown
this to be sensitive to BBB change in mild cognitive impairment, a precursor to Alzheimer’s disease, and are
currently using this technique in other neuro-infectious diseases. Second, we aim to assess the link between
circulating soluble markers, PBMC-associated markers, and BBB permeability to small molecules, which
collectively may promote diapedesis into brain. We target factors implicated in transmigration of activated
PBMCs across the BBB into brain, where they may contribute to neuronal damage and neuropsychiatric burden
in COVID long-haulers. After 3 years of funding, this R01 will advance our understanding of BBB integrity and
related PBMC migration into the brains of COVID long-haulers, which may contribute to neuroinflammation and
related neuropsychiatric burden. Findings will inform next steps in the development of therapeutic approaches
to minimize PBMC contribution to neuroinflammation in COVID long-haulers.

Public health relevance
PROJECT NARRATIVE Mild and moderate symptoms of SARS-CoV-2 infection last approximately two weeks for most individuals; however, for others the virus can cause lingering or emergent health problems including neurological and psychological issues. Integrity of the blood brain barrier (BBB) and immune cells migrating into the brain may contribute to neuroinflammation and related neuropsychiatric burden in COVID long-haulers. This project combines brain imaging, neuropsychiatric assessments, and blood-based measures of inflammation in COVID long-haulers and individuals without lingering COVID symptoms to understand the role of BBB permeability and inflammation as contributors to key aspects of cognition and mood.